RESOURCE SOFTWARE DEVELOPMENT &MAINTENANCE

This core effort provides support mechanisms for the software development projects undertaken by the Simulation Resource. It provides the internal management for the entire software development cycle, from conception to maintenance. It develops standards, provides tools and guidance to developers, and ensures that quality control is maintained. Additionally, it provides two essential services for our community of external users: (1) preparation of documentation for software products and (2) mechanisms for dissemination of software products.